Elucidating and overcoming T cell dysfunction in pancreatic cancer

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDA) is a lethal disease notoriously resistant to therapy including immune
checkpoint blockade. Meanwhile, immunotherapy targeting the PD-1:PD-L1 pathway is inducing stunning clinical
outcomes in other advanced malignancies. However, the underlying mechanisms governing immune
surveillance and resistance to a robust antitumor T cell response in pancreatic cancer are largely unknown. We
are poised to identify how to safely promote T cell-mediated destruction of pancreatic cancer through 2 funded
R01 applications and a collaborative P01 application. Our preliminary data support the hypothesis that immune-
mediated pancreatic cancer eradication requires the following components: 1) a high affinity tumor specific T
cell, 2) modification of suppressive intratumoral myeloid cells, and 3) overcoming chronic inflammatory and
immunosuppressive signaling pathways. Notably our results demonstrate that developing combinatorial
strategies to overcome endogenous T cell dysfunction in PDA may not be the same for enhancing cellular
therapy using T cell receptor (TCR) engineered based approaches. Thus, the 3 funded projects are based on
the development of highly faithful PDA animal models in which an endogenous or TCR engineered T cell
response can be tracked longitudinally over time. The projects are aimed at uncovering novel mechanisms that
interfere with the efficacy of combinatorial immunotherapies designed to engage the endogenous immunity
(project 1) or TCR engineered T cell therapy (project 2 and 3). We will test novel combinatorial approaches to
safely enhance the antitumor activity of a combination therapy that uses CD40 agonist, anti-PD-L1 (project 1) or
abrogating TGFb signaling in TCR engineered T cells (Project 2) or the combination of TCR engineered T cell
therapy and simultaneous modification of the desmoplastic tumor microenvironment (Project 3). Together the
studies will identify characteristics of T cells and the tumor microenvironment that produce durable antitumor
responses during immunotherapy.

Public health relevance
PROJECT NARRATIVE Pancreatic ductal adenocarcinoma (PDA) is a highly lethal malignancy with a dismal 5-year survival rate. PDA is often diagnosed at late stages, metastasizes early in pathogenesis, and is largely resistant to immunotherapy. In NCI-funded work, Dr. Burrack is utilizing an implantable syngeneic model to interrogate PDA-specific CD8 T cell biology and mechanisms of immunotherapy resistance mediated by the tumor micro-environment.